Albino Deletion Complex and Early Mouse Development

Chromatin remodeling complexes are essential for maintaining chromatin structure and transcriptional
regulation. The precise control of remodeling complex recruitment and assembly on targeted chromatin loci is
crucial for epigenetic memory. Various factors Include activation or repression of transcription, chromatin-
binding proteins, and histone modifications. These mechanisms are essential for mammalian
spermatogenesis, where epigenetic changes occur as germ cells transition from precursor to sperm.
Successful execution of the meiotic program necessitates the induction and repair of DNA double-strand
breaks to enable recombination between homologous chromosomes. Several factors involved in repairing DNA
damage in somatic cells are also involved in male meiosis. Chromatin-remodeling complexes, in addition to
regulating gene regulation, also play a role in DNA repair, regulation of gene expression, and meiotic sex
chromosome inactivation. Current experiments investigate how SWI/SNF and INO80 remodeling complex
subunits regulate epigenetic memory during spermatogenesis.

Public health relevance
Narrative Male infertility can result from abnormalities in the structure of proteins (chromatin) that package DNA within the nucleus (epigenetics). Proteins that modify chromatin alter histone-DNA contacts, disrupting DNA structure and gene expression. Genetic experiments that elucidate the specificity of these chromatin-modifying proteins may lead to targeted treatments.